Parameterizing the relationship between motor cortical reactivation during sleep and motor skill acquisition in the freely behaving marmoset

Project Summary/Abstract
This project will provide a more nuanced and mechanistic model of the role of sleep in memory consolidation,
particularly as it pertains to procedural motor skill acquisition in a non-human primate model. Motor skill
learning delineated by enhanced speed, automaticity, and accuracy of a correlate strongly with the duration of
non-REM (NREM) sleep. Neural reactivations of daytime neural activity preferentially occur during NREM, and
disruptions in NREM sleep negatively impacts memory consolidation. Since neural reactivations are not perfect
copies of daytime activity it is unclear what specific information about behavior and skill acquisition is being
reactivated during sleep. Do reactivations reflect certain parts or kinematic variables of the motor behavior
conducted during the day? Do changes in these reactivations predict certain features of future motor skill
improvements? We will develop a model that parameterizes the relationship between reactivation and memory
by measuring the dependence of motor skill learning on the number of reactivations, the fidelity of
reactivations, and, most importantly, the decodability of these reactivations each night and over subsequent
nights. That is, we will build decoding algorithms that accurately predict upper limb movements from neural
activity during the day and then use these algorithms to identify if spiking that is specific to certain kinematic
variables are preferentially reactivated. We will use the natural process of retrograde interference when a
subject learns a second motor skill following the first skill at various inter-task intervals to manipulate
reactivation and skill acquisition to more causally link reactivation to motor skill acquisition. Finally, our model
will enhance the standard sleep-consolidation framework using network science based tools to identify circuit
level changes: with a particular emphasis on higher order relationships between superficial and deep neurons
that are predictive of motor skill learning. To do so we will use wireless neural recordings from motor cortex
(M1) in unrestrained marmoset monkeys (Callithrix jacchus) will examine motor skill acquisition and sleep-
induced memory consolidation of these skills. Multi-electrode arrays with multiple contacts in depth will allow
us to systematically parameterize the interdependence of reactivations and network changes across cortical
lamina in M1 with motor skill performance. In Aim 1, we will measure changes in M1 population dynamics
across cortical lamina as monkeys engage in naturalistic and artificial motor skill acquisition tasks. In Aim 2, we
will characterize reactivations of skill-related neuronal activity patterns in M1 during sleep with a focus on the
behaviorally-relevant information content of these reactivations using population decoding methods and
functional network techniques. Finally, in Aim 3, we will examine retrograde interference and sleep reactivation
to naturally manipulate reactivation and skill acquisition. These aims will provide one of the first and most
comprehensive examinations of the role of sleep-induced reactivations of behaviorally relevant multineuronal
activity patterns in motor skill acquisition of the primate.

Public health relevance
This project seeks to provide a systematic and comprehensive examination of the role of sleep in motor skill acquisition. By using state-of the-art wireless multi-electrode array recordings from motor cortex during unrestrained motor skill acquisition, we will enhance our understanding of the functional reorganization of motor cortical circuits during motor learning and determine what cortical patterns during sleep improve motor skill acquisition. As we are using a primate model, this research may provide insights for enhancing motor skill acquisition in humans.